Advanced Platform Technology Center

The Advanced Platform Technology (APT) Center addresses the pressing clinical needs of disabled
Veterans by facilitating the creation and clinical translation of novel restorative or assistive devices and
therapies within a framework that promotes regulatory compliance, outsourcing by contract manufacturers,
clinical testing, and dissemination throughout the rehabilitation community. Its unique and supportive
environment enables VA investigators to develop advanced assistive or restorative technologies that serve
Veterans with sensory, motor, or cognitive deficits, as well as limb loss. The Center capitalizes on significant
local expertise in pursuit of research and development activities in four main clinical application areas:
Prosthetics & Orthotics, Health Monitoring & Maintenance, Activity-Based Neurorehabilitation, and Neural
Interfacing. The foundational technology enabling us to proceed from ideation and proof-of-concept through
first-in-man clinical feasibility testing and commercialization are developed by our Core Investigators in
collaboration with faculty in the Schools of Engineering and Medicine at Case Western Reserve University.
Specifically, we focus on new approaches to wirelessly reconnect disabled Veterans with their impaired organ
or sensorimotor systems and enable access to remote expert healthcare that meets them where they are
geographically and in their daily lives. We Innovate, Integrate, and Translate new rehabilitative and restorative
techniques and technologies for connected Veteran-centric health through omnidirectional communication of
information between the body, the therapeutic device, the user, and the outside world. Examples of new
initiatives and priorities for the 2025-2029 performance cycle include controlling incontinence and drug
resistant hypertension automatically and wirelessly via closed loop neuromodulation based on previous APT
Center technologies, delivering home-based vestibular rehabilitation and opportunities to exercise for disabled
Veterans with virtual reality, harnessing Internet of Things (IOT) technology to improve access to care
providers, and enhancing Veteran engagement via social media and web-based outreach.
We strive to pursue high impact projects that span the spectrum from new materials and microsystems for
communicating with the nervous system for novel neurotherapeutic or neuroprosthetic interventions to novel
active exoskeletons and other assistive devices that enable disabled Veterans to exercise, walk, and climb
stairs in their homes and communities. The Center has established the internal engineering, design control,
regulatory, communications and administrative support systems to accelerate its discoveries along the
translational spectrum to eventual clinical implementation. Our programs proactively facilitate generation and
protection of original intellectual properties, encourage interactions with the clinical services at the Medical
Center and throughout the VHA, and identify, mentor, and retain talented clinician-scientists dedicated to
improving Veterans health. These investments include start-up and bridge funding to seed new projects and
ensure continuity and progress between grants, Center-sponsored medical monitoring, purchasing and
budgetary management, medical illustration, statistical consulting, and translational services such as focus
groups and market analyses, increase productivity and efficiency of Center Investigators. As a result, APT
Investigators excel in securing significant independent support from multiple local, national, governmental, and
private agencies such as NIH, DARPA, NSF, and DoD in addition to Merit Review and other VA funding.
Investigators disseminate their findings broadly in prestigious peer-reviewed journals and lay media outlets, as
well as at clinical and scientific meetings. They work closely with the VA Technology Transfer Office to
establish corporate partnerships and license their technologies. We continue to create opportunities to
connect Veterans to the healthcare and restorative or rehabilitative interventions they need, while actively
educating and promoting future VA scientists from under-represented populations.

Public health relevance
The Advanced Platform Technology (APT) Center identifies, creates, and applies the latest scientific, technical, and clinical discoveries to improve the health and daily function of disabled Veterans. Application areas include Health Monitoring & Maintenance, Prosthetics & Orthotics, Neural Interfacing, and Activity-Based Neurorehabilitation for Veterans with limb-loss, or sensory, motor, or organ dysfunction and return them to productive roles in their homes and communities. Our unifying mission is to promote connected Veteran-centric health based on omnidirectional communication between body, user, technology, and the outside world. Specifically, we capitalize on advances in wireless communication, wearable sensing, automatic control, and remote monitoring to virtually connect disabled Veterans to their bodily functions, physical environments, and health care professionals. From discovery through pre-clinical and first-in-human trials, we actively accelerate innovative interventions along the translational pathway towards eventual clinical dissemination.